Efficiency and Safety of Microstimulation Via Different Electrode Materials

Summary
Our laboratory’s long-term goal is to understand and characterize the effects of microelectrode implantation,
recording, and stimulation on brain tissue from a physiological perspective in both neuronal and non-neuronal
cells, as well as to improve the biological compatibility, device stability, and performance of neural implants
through the use of advanced materials and tissue engineering approaches. The goal of the parent BRAIN
initiative R01 project is to understand the charge transfer, electrochemical, and biocompatibility properties of
electrodes on the efficacy and safety of microstimulation. Researchers have used Microstimulation to infer
functional connections between brain structures or causal links between structure and behavior. Currently,
microstimulation therapy is gaining interest for the restoration of visual, auditory, and somatosensory functions
in addition to applications in bioelectronic medicine. Current neural stimulation parameters and safety limits were
primarily established based on macro electrodes using postmortem histology. They should be revised for
microelectrodes using technologies that capture dynamic changes to neural tissue health and function. Another
challenge with micro-stimulation is its susceptibility to host tissue responses. Implantation of electrodes causes
electrode fouling, progressive neuronal loss, and inflammatory gliosis, leading to decreased stimulation
efficacy and increased impedance over long-term implantation. To address these challenges, the specific
objectives of this project are to assess the acute efficiency and safety limit of neural stimulation via different
electrode materials in vivo (Aim 1), examine the effects of stimulation on electrode materials and cultured cells
in vitro (Aim 2), and to characterize the chronic safety and stability of microstimulation in vivo from different
electrode materials (Aim 3). Diversity supplement funding is requested to support the research and training of
Ms. Anna Kelly, who is a recent graduate of the Bioengineering Department at the University of Pittsburgh. Ms.
Kelly will participate in the proposed research as a post-baccalaureate research assistant for at least one year,
pending grant approval. Ms. Kelly will conduct research directed toward both acute and chronic mouse studies
detailed in the parent award's first and third specific aims. In the acute studies, microelectrodes will be implanted
into the cortices of mice expressing genetically encoded calcium indicators and/or genetically labeled microglia
expressing a fluorescent protein. Through the use of 2-photon microscopy, the stimulation threshold and efficacy
of electrode materials and stimulation parameters will be assessed. After comprehensive training via participating
in these experiments, Ms. Kelly will conduct her independent project focusing specifically on the response of the
blood-brain barrier and vasculature to microstimulation. In particular, these studies will focus on the potential
effect of microstimulation on the leakage of cells and/or plasma and protein from the vasculature and the ensuing
response in the brain parenchyma, including potential changes to the morphology and behavior of pericytes and
vascular-associated microglia, which have been implicated in BBB leakage in response to inflammation.

Public health relevance
Narrative Diversity supplement funding is requested to support the research and career training of Ms. Anna Kelly, who is a recent graduate of the Bioengineering Department at the University of Pittsburgh and whose career goal is to become a physician-scientist to provide accessible care to her patients and to contribute to the science that impacts them. Ms. Kelly will receive research and career training under the parent grant investigating the charge transfer, electrochemical, and biocompatibility properties of electrodes on the efficacy and safety of microstimulation, with her independent research project under the parent grant focusing on the effects of microstimulation on the integrity of the blood-brain barrier and brain vasculature. This research and career training will be invaluable for Ms. Kelly in achieving her future goals of becoming a physician-scientist in neural engineering and will contribute significantly to her future success in the field.